Characterization of the gamma HV68 v-cyclin

[unreadable] DESCRIPTION (provided by applicant): This is the first renewal of a grant to investigate the mechanisms by which cyclin homologs encoded by γ-herpesviruses (v-cyclins) contribute to γ-herpesvirus pathogenesis and latency. The human γ-herpes viruses KSHV and EBV are important causes of cancer, especially in immunocompromised individuals. Because of the species specificity of these viruses, in vivo studies of their pathogenesis have been limited. We and others have been developing a small animal model system, infection of inbred mice with murine gammaherpesvirus 68 (yHV68), for analysis of the pathogenesis of γ-herpesvirus infection. This application focuses on the role of the γHV68 v-cyclin in disease pathogenesis. Notably, the γ2-herpesviruses (HVS, KSHV and yHV68) all encode homologs of D-type cyclins, while EBV infection upregulates expression of host D-type cyclins. Thus, we expect analysis of the γHV68 v-cyclin will provide important insights into a conserved pathogenic mechanism. We have shown that the γHV68 v-cyclin is an oncogene that promotes cell cycle progression in primary lymphocytes and that a γHV68 v-cyclin mutant reactivates inefficiently from latently infected Mφ and/or B cells (Progress Report). These observations lead to the following 4 aims. [unreadable] [unreadable] Aim 1. Role of v-cyclin during chronic infection [assess impact of dose and route of infection on acute virus replication, latency and reactivation; in vivo infection competition analysis with wt and v-cyclin null yHV68; further characterize v-cyclin null yHV68 reactivation defect; characterization of chimeric virus harboring KSHV v-cyclin]. [unreadable] [unreadable] Aim 2. Transcriptional regulation of v-cyclin gene expression [role of lytic cycle-associated v-cyclin gene transcription; analysis of latency/reactivation-associated spliced v-cyclin gene transcripts; characterization of P1- and P2-initiated LANA/v-cyclin spliced transcripts]. [unreadable] [unreadable] Aim 3. Develop and characterize tissue culture models to investigate v-cyclin functions [CDK-dependent function during acute virus replication; CDK-independent function during virus reactivation from latency]. [unreadable] [unreadable] Aim 4. Characterize CDK-independent v-cyclin function [map domains required for virus reactivation; gene expression profiling comparing wt and CDK-binding mutant v-cyclin; identify and characterize cellular and viral proteins interacting with v-cyclin]. [unreadable] [unreadable] [unreadable]